Administrative

The Administrative Core (Core B) will consist of the Program Director (10% effort) and two assistants each with partial effort. One is Ms. Lisa Russell, administrative assistant, who will perform duties related to grant preparation, grant reporting, manuscript preparation, human and animal subjects review and arranging meetings and conference calls among the PPG investigators, the internal advisory committee and the external advisory committee, and other non-financial issues mentioned below. She will need to be appointed at 50% effort to perform all of these duties. The other is Ms. Cher Herh, a grants management specialist who will manage all financial components of the grant including a) prior to submission, preparing financial elements of the application, b) performing all postfunding accounting on a continuing daily basis with monthly reports to the Program Director, project and core leaders, and c) supporting annual reporting for all four projects and two cores. She will be appointed at 25% effort. In addition, our Senior Electronics/Computer Technician Mr. Jeff Struthers will provide 10% effort within the Core to support maintenance of computers and peripheral equipment used in research in all projects and cores. The remainder of his time is distributed among the projects to support each project's unique research equipment electronics and hardware needs. This is both in maintenance of existing equipment and in the development of new equipment.